Solid-State Nanopores integrated with Nanoporous Membranes for enhanced Single-Molecule Counting of low-abundance Biomarkers

Abstract Rapid progress in the discovery of disease biomarkers commands the development of high-performance detection systems that can achieve the requisite levels of speed, sensitivity and accuracy. With extraordinary sensitivity and dynamic range, solid state nanopore (ssNP)-based electrical counting methods are the leading candidates to meet this need. In processing one molecule at a time however, ssNPs must overcome a major challenge in throughput before they can be used to analyze clinical samples. This project will develop a novel dual membrane device (NPN/ ssNP) to address two critical issues limiting nanopore performance: short lifetimes and diffusion-limited capture rates. The enabling feature of the device is the addition of a highly porous silicon nanomembrane (NPN) immediately upstream of the ssNP. The membrane serves as a filter to prevent clogging and enables microfluidic delivery of biomarkers. When combined with parallelization and biomarker amplification, the dual membrane device should yield a 106 improvement in throughput, enabling ssNP technology to detect biomarkers at sub-picomolar clinical concentrations in practical time periods (minutes). The project will establish proof-of- principle in work organized under three Aims. Aim 1 thoroughly characterize the new device and produce an optimum configuration for DNA capture. Aim 2 will elucidate the benefits of microfluidic delivery of sample. Finally, Aim 3 will apply the lessons of Aims 1 and 2 to maximum benefit and demonstrate the detection of fM concentrations of biomarker in under 10 minutes from 10 ul of blood plasma.

Public health relevance
Narrative The speed and sensitivity of solid-state nanopores make them ideal candidates for the detection of low abundance biomarkers, however they currently operate below their potential due to low event rate and pore clogging issues. This project introduces novel technology that addresses both of these issues. The goal of the project is to demonstrate the use of the new technology to detect fM concentrations of biomarker in 10 ul of blood plasma in under 10 minutes.